Using defective lipoylation as a window into cardiac fuel consumption and failure.

Project Summary
Metabolism is essential for normal cellular function and dynamically changes to meet organism and tissue
needs. Cardiac function and metabolism are closely intertwined. Fatty acid oxidation serves as the primary
means to provide energy in normal conditions. In heart failure, cardiomyocytes lose this metabolic flexibility and
become more reliant on glycolysis. Despite extensive work to understand the metabolic underpinnings of heart
failure, more investigation is needed to dissect the underlying mechanisms of this disease.
A class of metabolic diseases collectively known as inborn errors of metabolism (IEMs) provide a window
into pathophysiology, including heart failure, due to their well-defined causes. Pathology arising from IEMs can
be tracked back to a single mutation, providing a direct and tractable method of studying the disease. Lipoic acid
deficiencies are a novel class of IEMs that cause metabolic decompensation, severe neurodevelopmental
delays, and early death. Lipoyltransferase-1 (LIPT1) catalyzes the final step in de novo lipoic acid synthesis by
transferring the lipoate moiety to 2-ketoacid dehydrogenases such as pyruvate dehydrogenase (PDH),
oxoglutarate dehydrogenase (OGDH), and branched-chain ketoacid dehydrogenase (BCKDH).
The Genetic and Metabolic Disease Program (GMDP) at UT southwestern has unique access to patient
samples and clinical data. A LIPT1 deficient patient presented with neurodevelopmental delays and numerous
unexpected metabolic phenotypes, including elevated serum 2-hydroxyglutarate (2HG), a metabolite with wide
ranging impacts on cell signaling and epigenetic regulation. The patient also displayed altered cardiac function,
including impaired systolic function and tachycardia secondary to atrial fibrillation, worsened by acute episodes
of metabolic decompensation. We intend to characterize the underlying causes of cardiometabolic distress using
novel mice to model cardiac LIPT1 deficiency. Mice lacking LIPT1 in the heart die within 6-7 weeks with severe
systolic dysfunction and elevated levels of 2HG. The central hypothesis of this proposal is that LIPT1
deficiency pathologically limits cardiometabolic flexibility leading to deleterious metabolite
accumulation, including 2HG, and impaired cardiac development and function.
If successful, this proposal will generate a definitive assessment of cardiac LIPT1 deficiency in mice
providing a detailed understanding of the metabolic consequences of this specific IEM. More broadly, this
proposal will increase our understanding of the consequences of limited metabolic flexibility in cardiac tissue, a
hallmark of heart failure. The appropriate usage of both patient data and mouse models will increase the disease
relevance of the work discussed in this proposal.

Public health relevance
Project Narrative The heart relies on specific nutrients like fatty acids to function normally and demonstrates metabolic flexibility (e.g., glucose utilization) in heart failure and altered nutrient environments. Multifactorial diseases like heart failure may be better understood in the context of inborn errors of metabolism (IEMs), a class of monogenic diseases caused by mutations in metabolic enzymes. Uncovering the consequences of LIPT1 deficiency, an IEM that can cause severe multi-organ dysfunction including cardiac failure, will enhance our understanding of the mechanisms driving heart failure and potentially uncover novel therapeutic opportunities.